Prevention of macular pathophysiology associated with F3 misfolding

ABSTRACT
Age-related macular degeneration (AMD) is the leading cause of irreversible blindness in people
greater than 60 years of age in industrialized countries. Worldwide, it is estimated that nearly
300 million people will have some form of AMD by 2040. Thus far, no effective treatment exists
for halting dry AMD progression, the form which affects 90% of all AMD patients. The only
suggestion for slowing this form of AMD is to take high-dose vitamin and mineral supplements
daily. Emerging evidence suggests that mutations or alterations in fibulin-3 (F3), a secreted
protein of unknown function, plays a prominent role in influencing the pathogenesis of macular
degenerative diseases. One specific example is how an R345W mutation in F3 causes an early
onset macular dystrophy called Malattia Leventinese (ML), which is characterized by
complement activation, production of inflammatory cytokines, as well as sub-retinal pigment
epithelium (RPE) deposits. However, in general, there is a lack of knowledge regarding how
these macular degenerations develop. Furthermore, there are no effective treatments for either
ML or the more prevalent disease, dry AMD. Therefore, there is an urgent need to develop a
mechanistic understanding of the underlying causes of AMD-like diseases, such as ML, and to
identify new therapies for them. In this proposal we plan to i) test genetic strategies directed at
preventing the secretion of misfolded R345W F3 from RPE cells, ii) employ a novel, conditional
approach to regulate inflammatory signaling downstream of R345W F3 misfolding, and iii) test
whether WT F3 is also necessary for sub-RPE deposit formation. At the end of the study, we
hope to have a better understanding of the molecular basis by which misfolded F3-facilitates
inflammation and sub-RPE protein deposition, and to identify a number of therapeutically-
tractable approaches for treating ML. The insight that we gain regarding how misfolded F3 is
involved in triggering inflammation and sub-RPE deposits can likely be applied more broadly to
prevalent retinal diseases such as dry AMD.

Public health relevance
PROJECT NARRATIVE Age-related macular degeneration (AMD) is a complex and prevalent blinding disease that affects millions of Americans. Increasing evidence suggests that alterations in a protein, fibulin- 3, play a role in the initiation and propagation of key phenomena in AMD. This project will identify how these alterations in fibulin-3 ultimately trigger phenotypes in observed in AMD, thereby uncovering potential therapeutic strategies to treat AMD and similar, fibulin-3-based diseases.